Prospective Investigation of Cirrhotic Cardiomyopathy in Humans

PROJECT SUMMARY
Cirrhotic cardiomyopathy (CCM) is a recognized but understudied and not well understood complication of
cirrhosis. CCM is defined as subclinical diastolic or systolic dysfunction by echocardiography in patients with
cirrhosis in the absence of overt coronary artery, valvular, or pericardial disease. Drs. Izzy (PI) and VanWagner
(co-I) cofounded the multidisciplinary CCM consortium in 2018 that established diagnostic criteria for CCM in
2020 incorporating contemporary echocardiographic methods. Since then, mostly retrospective, and relatively
small studies applying these criteria suggest CCM may be common affecting 24-45% of patients with cirrhosis
and associated with adverse hepatic and cardiac outcomes and ~2-to 9-fold greater risk of death. Further, the
pathophysiology of CCM in humans is not well understood, but preclinical evidence from our group and others
implicates bile acids (BA) as a causal and potentially modifiable driver of CCM. Appreciating limitations of
retrospective human and preclinical studies, the estimates for CCM prevalence and prognosis are concerning
and motivate deeper and larger prospective investigation in humans to address unanswered questions highly
relevant to clinical care and those of biologic importance. These include 1) what are the associations between
CCM and all-cause mortality, cirrhosis-related outcomes, and adverse cardiac events, 2) what clinical factors
associate with presence of CCM, and 3) do BA associate with adverse cardiac remodeling and features of
CCM? Therefore, in this study we will conduct the first US based prospective investigation of CCM in humans
with decompensated cirrhosis enrolled from two high-volume hepatology and liver transplant (LT) centers. Our
study design will address limitations of prior studies by including a) larger sample size inclusive of both eligible
and ineligible patients for LT, b) serial assessment every 6 months of clinical, laboratory, and
echocardiographic data, and c) longitudinal ascertainment of hepatic, cardiac, and mortality outcomes. Our
specific aims are to: 1) test the hypothesis that addition of CCM status to MELD-3.0 improves accuracy of risk
stratification for 1-year all-cause mortality, 2) define clinical risk factors associated with CCM, and 3) test the
hypotheses that higher circulating levels of total BA and altered composition of BA (ratio of conjugated primary
BA [cholic and chenodeoxycholic acids] to secondary BA [ursodeoxycholic acid]) associate with the cardiac
alterations seen in CCM. By providing foundational prospective data needed to advance the field of CCM, our
study will exert a powerful and enduring scientific and clinical impact. We will refine clinical risk stratification for
adverse outcomes in patients with end-stage liver disease and inform clinical screening and surveillance for
CCM. Establishing a CCM risk profile and a BA-myocardial link are critical to designing future trials testing BA
modifying therapies specific for CCM, particularly as pharmacotherapy for CCM are lacking. Our team of
experts in hepatology, BA, cardiology, epidemiology, and biostatistics has the requisite resources to
successfully complete the study, which will transform understanding of and the clinical approach to CCM.

Public health relevance
PROJECT NARRATIVE Cirrhotic Cardiomyopathy (CCM) is a recognized complication of cirrhosis, but understudied despite recent retrospective data suggesting it may be common, affecting one in three patients with decompensated cirrhosis, and associated with significantly increased risk of death and adverse hepatic and cardiac events. Moreover, evidence from preclinical models and children suggest elevated bile acids may contribute to CCM, but data from adults with cirrhosis are scarce. Therefore, we will conduct the first contemporary prospective multi-center investigation of CCM in adults in the USA to define its prognostic significance and clinical risk factors, while deepening understanding of bile acids as a contributor to CCM and a potential therapeutic target.